COMPUTING SERVICES FOR THE DIVISION OF CANCER PREVENTION (DCP)

Computing Services for Division of Cancer Prevention (DCP) This requirement provides computing services to DCP divided into six fully integrated and cohesive task areas: Task Area 1. Project Management/Core Services Task Area 2. Data Management Task Area 3. Computer Programming Task Area 4. Computing Infrastructure Services Task Area 5. Website Development Task Area 6. Systems Design and Development